GIBBS MOTIF SAMPLING--DETECTION OF BACTERIAL OUTER MEMBRANE PROTEIN REPEATS

A new Gibbs sampling algorithm is described that detects motif-encoding in sequences and optimally partitions them into distinct motif models; this is illustrated using a set of immunoglobulin fold proteins. This algorithm extends previous work in this area in three ways: 1) The requirement for the specification of the number of motifs in each sequence has been relaxed. 2) The length of the motif is now automatically determined by the algorithm, 3) A non-parametic test for the significance of the alignment has been developed. When applied to sequences sharing a single motif, the sampler can be used to classify regions into related submodels, as is illustrated using helix-turn-helix DNA-binding proteins. This feature permits the algorithm to simultaneously align the sequences and classify segments into sub models. Other statistically-based procedures are described for searching a database for sequences matching motifs found by the sampler. When applied to a set of thirty-two very distantly related bacterial integral outer membrane proteins, the sampler revealed that they share a subtle, repetitive motif. The broad conservation and structural location of these repeats suggests that they play important functional roles.